Structural and functional determinants of decision-making in bacteriophage host recognition

PROJECT SUMMARY/ABSTRACT
In response to NOT-GM-22-017, Notice of Availability of Administrative Supplements for
Equipment Purchases for NIGMS Awardees, we request the funds to purchase one ÄKTA pure
25 M liquid chromatography system and a set of chromatography columns most suitable for the
work proposed in the parent grant R01GM139034. The parent grant aims to establish the
mechanisms by which viruses recognize their host cells, undergo a conformational change, and
irreversibly attach to the cell surface. Using several bacterial viruses (bacteriophages) as model
systems, the project aims to determine the role of different phage virion components in the
attachment process, the energetics of host cell surface recognition, and the structure of the phage
particle in the midst of host cell envelope penetration. Individual virion components, viral host-
attachment organelles, complete phage particles, and various components of the host cell – oligo-
and polysaccharides, including O-antigens, and membrane proteins – will be studied using X-ray
crystallography, cryo-electron microscopy, and solution biophysics. High quality and high purity
preparations of macromolecules and their complexes are essential for the success of these
studies. Such preparations can be made possible by the ÄKTA pure 25 M liquid chromatography
system equipped with the proposed set of chromatography columns that include a high
capacity/high resolution anion exchange column, analytical (small volume and high resolution)
size exclusion columns and preparative (large volume) size exclusion columns with the latter two
types targeting different molecular weights of macromolecules. The purification system and the
columns will be made available to other NIH-funded investigators should the need arise.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) The aim of the parent grant is to describe the activation and structural transformation of the virus particle during host attachment using several bacterial viruses as models. Bacterial viruses (bacteriophages) are being developed into diagnostic and therapeutic tools for treatment of antibiotic resistant infections. The supplement requests funding to acquire a high performance liquid chromatography system, which is required to accelerate the structural and functional studies outlined in the parent grant.